Neuromorphic encoding of tactile stimuli to provide naturalistic sensory feedback in upper limb prostheses

PROJECT SUMMARY
This research project is motivated by the goal of improving the lives of amputees through
naturalistic sensory feedback of tactile stimuli. Today, prostheses rely on decoding user intention through
measurement of neural or electromyographic (EMG) signals. The full potential of these sophisticated
robotic devices cannot be realized without the incorporation of sensors that evaluate the environment and
a way to seamlessly communicate with the user. Neural prostheses can enable this seamless communication
by interfacing directly with the nervous system of amputees and stimulating the nerves in order to elicit
sensations corresponding to the interaction between the prosthesis and the environment. To do this
naturalistically, the analog readings from sensors incorporated into the prosthesis must be encoded into the
language of the nervous system: patterns of spiking activity. My goal is to improve sensory feedback for
amputees by exploring how information from tactile sensors can be transformed into neuron-like
(neuromorphic) spikes to be used for stimulation feedback. I will examine how tactile sensing is encoded
in biology and then phenomenologically recreate the signal processing chain using a computational model
that will be tested with a real-world texture dataset. The output of these models will be classified to verify
and quantify the successful encoding of texture information as neuromorphic spiking activity. Texture
serves as a good test case to develop these models because of its rich spatiotemporal structure.
Specific Aim 1 – Neuromorphic Encoding and Processing of Tactile Stimuli – I will use the Izhikevich
neuron model to recreate the spiking activity of SA and RA mechanoreceptors in response to texture stimuli
applied to a tactile sensing array. I will develop new algorithms to transform the spiking patterns to account
for scanning speed and applied force. This will result in a speed- and force-invariant representation of
texture.
Specific Aim 2 – Neuromorphic Compression of Tactile Information – Initially, a naïve channel
selection algorithm that uses spike train distance to evaluate mutual information between different input
channels will compress tactile information to select an optimal set of sensing channels to pass through to
stimulation. A more advanced scheme will combine inputs together for more efficient information encoding
and to enrich the information content of the final output spiking patterns. Artificial texture classification
will be used to evaluate the capability of these methods to efficiently retain relevant texture information.
Fundamentally, Aim 1 focuses on robust representations of tactile stimuli independent of
exploratory conditions, while Aim 2 focuses on efficient representations of those stimuli. When completed,
this work will provide the basis for more naturalistic sensory feedback to amputees through peripheral nerve
stimulation which will result in better functional outcomes when using prostheses in their daily lives.

Public health relevance
PROJECT NARRATIVE This research will develop computational models to enable naturalistic sensory feedback of tactile stimuli to amputees which will improve functional outcomes in their daily lives. In particular, the computational models will mimic biological processing to encode tactile stimuli as robust and efficient neural representations. The bio-inspired techniques created in this work also will more broadly apply to the development of neural prostheses for other sensory modalities.